In vivo essential genome of Salmonella

SUMMARY
Defining genome-wide genetic requirements for fitness of a bacterial pathogen in the host is a fundamental
goal of pathogenomics. Transposon sequencing (Tn-seq) is a power functional genomics tool for genome-wide
identification of essential and conditionally essential genes in bacteria. When applied to a bacterial pathogen
with an appropriate animal infection model, Tn-seq can accelerate the discovery of the genetic determinants of
a bacterial pathogen for in vivo fitness. However, the full potential of this powerful approach to understand
bacterial virulence determinants is often hampered by the bottlenecks associated with animal infection models.
The bottlenecks cause stochastic loss of the mutants without contribution of their genotypes, which can lead to
false positive discoveries. In this application, we will develop a novel strategy to overcome this limitation by
employing a transposon system that generates a genome-saturating random mutant library from the bacterial
cells multiplied from a small seeder population established in the target host tissue upon induction,
circumventing the bottleneck problem. The Tn-seq profile obtained from the genome-saturating mutant
population recovered from the host tissue would allow genome-wide identification of in vivo essential genes by
the genes lacking insertions in the same manner by which in vitro essential genes are identified. This new
approach will be fully developed and evaluated (Aim1) and applied for genome-wide identification of the gut
colonization factors of Salmonella Typhimurium 14028 during infection in mice (Aim 2). Once established and
validated, this approach can be easily extended to other bacterial pathogens to fully explore in vivo essential
genomes.

Public health relevance
RELEVANCE Comprehensive identification of the genes in Salmonella Typhimurium, an important human bacterial pathogen, that are required for gut colonization during host infection is critical to elucidate complex mechanisms utilized by this pathogen to cause disease in the host. In this study, we will develop and use a novel approach to perform genome-wide identification of the in vivo essential genes required for gut colonization by S. Typhimurium in mice. Once established this approach can be easily extended to other bacterial pathogens to fully explore in vivo essential genomes, which will in turn accelerate the development of improved therapeutic options to treat bacterial pathogens.